Cerebellar Circuits

Abstract
The cerebellar cortex transforms mossy fiber inputs to granule cells, into predictions in the form of Purkinje cell
outputs, and facilitates learning through synaptic refinement to correct inaccurate predictions. This scheme
was originally advanced to account for motor control and motor learning, but we now know that the cerebellum
is also critically involved in social and emotional behaviors, balance, cognition, and learning in reward tasks.
The traditional view is that the same simple circuit comprised of a small number of cell types is repeated
throughout the cerebellar cortex, with the only difference being the source of the inputs and the targets of the
outputs. It is unlikely that this simple circuit captures the full complexity of cerebellar processing, particularly in
light of our recent study that revealed many subtypes of cells: 9 Purkinje cells, 2 molecular layer interneurons,
3 Purkinje layer interneurons, 2 Golgi cells, 5 granule cells, and a continuum of unipolar brush cells. This
tremendous complexity indicates that the basic cerebellar circuit is incomplete. The primary goal of my
laboratory during the next eight years is to answer the following question: How do these different subtypes of
cerebellar neurons contribute to signal processing and behavior? Clarifying the roles of these newly identified
cell types and subtypes promises to lead to a new understanding of cerebellar processing. We also found that
many of these cell types are differentially distributed within the cerebellar cortex. How is cerebellar circuitry
regionally specialized to contribute to diverse behaviors? To answer these questions, we generated and
acquired intersectional mouse genetic tools to precisely target cell types and subtypes, we combined
electrophysiological and optogenetic methods to assess connectivity, we generated a large serial EM data set
to reconstruct cerebellar circuits, we established in vivo multielectrode recording techniques, we established a
battery of behavioral tests to assess cerebellar function, and we developed a highly constrained model of the
cerebellar cortex. In the past three years, we began to study all types and subtypes of neurons in the
cerebellar cortex and established a solid foundation for future investigations. Achieving the goals of this R35
promises to revolutionize our understanding of how different types and subtypes of neurons contribute to
cerebellar processing. This will provide crucial insights for understanding how cerebellar dysfunction leads to
neurological disorders.

Public health relevance
Research Narrative The discovery of new types and subtypes of cerebellar neurons, new signaling mechanisms, and the involvement of the cerebellum in diverse behaviors, makes it necessary to update the cerebellar circuit framework to understand how the cerebellum controls distinct behaviors. We use mouse genetic tools, electrophysiological and optogenetic techniques, serial electron microscopy for circuit reconstruction, behavioral assays, and computational methods to explore the physiological properties, connectivity, and behavioral roles of newly identified cerebellar neuron types and subtypes. We will also clarify how signaling mechanisms, such as Purkinje cell feedback, gap junction coupling, specialized spillover synapses and ephaptic signaling contribute to cerebellar processing.